CORE D: BIC Core

SUMMARY/ABSTRACT
Brain Imaging Core
This Center for Neurodegeneration and Translational Neuroscience (CNTN) COBRE Phase 2 application seeks
the continuation of success achieved with the COBRE Phase 1 funding and includes a request to establish a
Brain Imaging Core (BIC). The primary goals of the BIC are to expand and improve imaging and analytic data
analyses methods, which will increase the success of the Phase 2 projects, generate new pilot projects, and
establish collaborations with researchers from University of Nevada-Las Vegas (UNLV) and other Institutional
Development Award (IDeA) state communities with interests in neuroimaging. Successful interaction of the BIC
with the other Cores (Data Management and Statistic Core [DMSC], Clinical and Translational Neuroscience
Core [CTNC]) and Phase 2 Junior Investigators (JIs) provides opportunity for advancement to independent
research careers, build neuroscience infrastructure in Nevada, and advances the understanding of Alzheimer’s
disease (AD) and Parkinson’s disease (PD). Expert imaging and analytic capability is essential for supporting
research and training and provides a foundation for transition of the BIC to a self-sustaining core. The major
goals of the BIC are to provide support for JIs in neuroimaging research and to further characterize patients and
cognitively normal controls using imaging and analytic data analyses. Furthermore, the BIC will develop tutorials
for training on imaging and data analysis methods and will advance novel methods to better characterize patients
with neurodegenerative disorders resulting in improved assessment, diagnosis, classification, and prediction
accuracies, as well as tools for translational discovery. Imaging and data analysis approaches will be
strengthened for all COBRE projects and the availability of analytical methods and training will provide significant
support to JIs and other researchers throughout the COBRE system. Robust interactions between the brain
imaging group that will comprise the BIC and collaborators in Phase 1 supports the creation of this new core in
the CNTN.

Public health relevance
NARRATIVE Brain Imaging Core The Center for Neurodegeneration and Translational Neuroscience (CNTN) COBRE Phase 2 Brain Imaging Core (BIC) will provide advanced neuroimaging technologies and data analysis methods to current and future COBRE projects and other interested researchers. The BIC will be committed to the training of junior investigators in advanced imaging methods and analyses, as well as advancing the sustainability of the Core and the CNTN. The proposed BIC is highly relevant to public health because it promotes training, access and usage of advanced neuroimaging technologies, and data analysis methods leading to better characterization of human brain function and thus will promote advancing understanding of neurodegenerative diseases.